Lipid Aldehyde and Ethanol Induced Liver Damage

Alcoholic liver disease (ALD) is a significant source of morbidity and mortality in the United States. ALD is a progressive disease encompassing hepatic steatosis, steatohepatitis, fibrosis and cirrhosis. It is widely accepted the molecular mechanisms underlying ALD are multifactorial including compromised antioxidant systems and the overproduction of reactive oxidant species having the potential to modify hepatocellular lipids, proteins and nucleic acids. The oxidant-mediated modification of lipids, and the resulting modification of key proteins critical for hepatocellular homeostasis, are important mechanistic events contributing to initiation and/or progression of ALD. The working hypothesis underlying the proposed experiments is focused on the proposition that protein modification occurring as a consequence of lipid peroxidation, protein glycosylation or acetylation are significant events in the pathogenesis of ALD. During the previous funding period of this MERIT AWARD, significant progress was made in refinement and development of state-of-the-art proteomic approaches for isolating, identifying and functionally characterizing proteins modified by the lipid peroxidative products 4-hydroxynonenai (4-HNE). Significant progress was also made in development of mouse and rat models of ALD to probe specific components of hepatic dysregulation associated with oxidative stress. In addition, the use of bioinformatic approaches to identify components of metabolic pathways and biologic systems impacted by alcohol-induced oxidative stress were developed. These combined experimental approaches will be used to test our working hypothesis in the following three specific aims: Experiments in Aim 1 will continue characterization of the functional consequences of alcohol-induced changes in the hepatic proteome resulting from 4-HNE, glycsoylation or acetylation using our recently developed mouse models which displays predictable progression from steatosis to steatohepatitis. Studies in Aim 2 will identify the modified proteomes using our recently developed PPAR?, GSTA4-4 double KO mice. Aim 3 will explore the role of autoimmunity in progression of ALD by evaluating modified proteomes in B6.12957-Rag1 mice as well as the triple KO B6.12957-Rag1- PPAR?-GSTA4-4 mice to aid in identification of mechanisms involved in the immune response. Collectively, the mechanistic information derived from these experiments will provide new insight into novel therapeutic strategies to attenuate ALD.

Public health relevance
Alcoholic liver disease (ALD) is a significant cause of morbidity and mortality in the United States. Given the prevalence of this disorder the resulting financial impact on our health care system is significant. There is general agreement among researchers who study this disease that it is a multifactorial and complex disease complicating discovery of effective therapeutic strategies for arresting initiation and progression of this syndrome. The studies proposed in this application have a high probability of identifying cellular mechanisms of this disorder which could lead to development of effective strategies and therapeutic agents for treatment of ALD.